Vaccine and Treatment Evaluation Units: A Phase I Trial to Study a TB Therapeutic

The Vaccine and Treatment Evaluation Units (VTEUs) are a consortium of individual contracts within academic centers and organizations that provide a ready resource for the design and conduct of clinical trials to evaluate promising vaccines and treatments for infectious disease. Investigations of novel product delivery systems and routes of delivery may also be conducted. This study includes a Phase I clinical trial.